Defining neutrophil pathobiology in pediatric Long COVID

Over 15.6 million children in the U.S. alone have been infected by SARS-CoV2. While most recover, roughly 1
million children suffer from Long COVID. Neutrophils have been shown to be hyperactivated in Long COVID,
which is concerning because they can be quite inflammatory, causing vascular and tissue damage and
contributing to disease. We aim is to define the neutrophil profiles driving Long COVID in order to ultimately offer
novel strategies for diagnosing and treating this new disease. To achieve this goal, we will use both single-cell
RNA sequencing technology to define neutrophil activation profiles and microfluidics to test neutrophil
functionality Long COVID, compared to healthy controls. Our central hypothesis is that neutrophil activation in
Long COVID carries a distinct neutrophilic gene expression and functional profile, which contributes to
pathogenicity. Importantly, we aim to partner with an existing clinical trial of larazotide for Long COVID
(ClinicalTrials.gov Identifier: NCT05747534) to test reversibility of neutrophil activation by targeting sources of
Spike antigenemia. Ultimately, mechanisms driving the pathogenesis of this newly emerged post-COVID-19-
related illness must be defined to establish diagnostics and effective therapies.

Public health relevance
Neutrophils are immune cells that are critical for containing and clearing an infection, yet they have the capacity to damage tissue and contribute to microclot formation if over activated. Neutrophils may play an important role in pathogenesis of Long COVID. Here, we aim to define neutrophil phenotypes with single-cell RNA sequencing and test neutrophil functionality and contributions to microclot formation in order to define the role of the neutrophil in pediatric Long COVID. Our goal is to unveil novel strategies for diagnosing and treating Long COVID with the goal of improving health outcomes in these children.